Handoff Effectiveness Research in periOperative environments (HERO) Collaborative Research Conference

Project Summary Perioperative transfers-of-care or “handoffs” are high-risk, error-prone events known to contribute to patient harm, yet there remain substantial evidence gaps with respect to the interventions clinicians and healthcare organizations can implement to reliably decrease harm. Further, much of the current handoff research remains in domain silos (e.g., hospitalists, nursing) limiting our ability to learn from each other and advance the field. The Multicenter Handoff Collaborative (MHC) was formed in October 2015 with the vision of eliminating unintended harms during perioperative (i.e., pre- through post-operative) patient handoffs. Several meetings of the collaborative have established that further research is necessary to generate solutions addressing this evidence gap, and a meeting across disciplines is necessary to align stakeholders and begin to develop a thematic research strategy. We are now requesting an AHRQ Conference Grant to support convening the Handoff Effectiveness Research in periOperative environments (HERO) Collaborative Research Conference (CRC). The objective of the Handoff Effectiveness Research in periOperative environments (HERO) Collaborative Research Conference (CRC) is to align relevant stakeholders and develop and disseminate a perioperative handoff research agenda through the following specific aims: Aim 1: Identify the Evidence Gaps. Review the evidence base on perioperative handoffs and care transitions to identify: a) important knowledge and application gaps; and b) the strengths and shortcomings of available process and outcomes measures that link best practices to improvements in patient safety. Aim 2: Develop Thematic Research Strategy and Define Infrastructure Needs. Develop a thematic research strategy and determine the infrastructure requirements for conducting rigorous multicenter studies capable of demonstrating: a) reductions in harm associated with improved handoffs; b) scalable implementation strategies; and c) education curricula capable of building competencies in team-based communication. Aim 3: Promote Stakeholder Synergy. Characterize the interests, priorities and capabilities of all of the major stakeholders to facilitate the conduct of multi-center perioperative handoff trials, and the subsequent rapid dissemination and translation of best practices that reduce patient harms and are generalizable to other domains.

Public health relevance
Project Narrative Over thirty-five million people undergo surgery annually in the United States. It is well accepted that perioperative handoffs contribute to patient harm, and yet there remain appreciable evidence gaps with respect to the causes of handoff-related harm and interventions that clinicians and healthcare organizations can implement to decrease that harm. The proposed Handoff Effectiveness Research in periOperative environments (HERO) Collaborative Research Conference (CRC) will convene a nationally-representative group of stakeholders to develop a thematic perioperative handoff research agenda and define infrastructure needs for conducting this research. Conference products will include: a) written publication of the conference proceedings, b) creation of a site development toolkit, and c) defined objectives for subsequent research conferences, which will position the field to embark on a targeted research path towards eliminating harm from perioperative handoffs.